Mitochondrial Aging Promotes Inflammation

PROJECT SUMMARY/ABSTRACT
Mitochondrial Aging Promotes Inflammation
Aging is often associated with a progressive decline in health, resulting in reduced quality of life that limits health
span, defined as the number of years spent in good health. Of the many cellular processes that decline with age,
changes in the mitochondria are significant because numerous studies show a link between altered mitochondrial
function and the development of age-associated diseases. Our studies, funded by the current R15 award, show
that aging promotes an increase in the localization of STAT3 to the mitochondria (mitoSTAT3), which induces
profound changes in mitochondrial structure, dynamics, and function and has a mechanistic link to
proinflammatory Th17 cytokine production. Th17 cytokines (IL-17A, IL-17F, IL-21) and Th17 supportive cytokines
(IL6, TNFα) are specifically known to promote age-associated pathologies such as Alzheimer's and dementia,
diabetes, and several forms of autoimmunity and malignancies. In our studies, mitoSTAT3 increased the
OXPHOS dependence of aging T cells and regulated mitochondrial complex II; succinate dehydrogenase (SDH).
Limiting mitoSTAT3 using mitochondria-targeted STAT3 inhibitor, Mtcur-1, lowered complex II expression and
activity, prevented age-induced changes in mitochondrial structure, dynamics, and function, and reduced
proinflammatory Th17 inflammation. Exogenous expression of the constitutive serine phosphorylated form of
STAT3, a required phosphorylation for mitochondrial translocation, in T cells from young adults mimicked
changes in mitochondrial function in T cells from older adults and promoted the production of Th17 supportive
cytokines. The data also showed the involvement of additional key but yet-to-be-identified factors that support
Th17 inflammation concertedly with mitoSTAT3. Our recent data point to dysregulation in Nuclear factor erythroid
2-related factor 2 (NRF2) signaling as another potential mechanism in promoting age-related inflammation. The
proposed work will evaluate (i) crosstalk between autophagy and mitoSTAT3 and (ii) regulation of
metabolism and redox signaling by NRF2 as dominant mechanism(s) of CD4+ T cell inflammation during
aging. We will utilize pharmacological and genetic loss-and-gain of function approaches to modulate autophagy
mitoSTAT3, NRF2 and related proteins. This mechanistic work will map the age-sensitive regulatory
mechanisms and pathways operational in T cells that promote inflammation. The study's overarching goal is to
identify pathways and druggable targets for preventing the onset of inflammatory diseases during aging and
improving health span.

Public health relevance
PROJECT NARRATIVE: Mitochondrial Aging Promotes Inflammation The dysregulation of function of the mitochondria and homeostasis mechanisms, such as autophagy and redox, significantly impact aging-associated inflammatory diseases, cancer progression, and cardiovascular diseases. The work proposed in the renewal application will evaluate the inter-regulation between mitoSTAT3 and autophagy(Aim1), NRF2 dependent metabolic reprogramming and signaling (Aim 2) and their mechanistic link to age-associated CD4+ T cell inflammation. The overarching goal is to identify druggable targets to prevent the onset of age-associated inflammatory diseases and improve health span; length of life spent in good health.